Protective role of Honokiol in preventing c-Met-induced post-transplantation cancer

PROJECT SUMMARY
Cancer is a critical problem in immunosuppressed patients, particularly, who receive organ transplants; and
kidney/renal cancer is one of the major cancers in these patients. Direct tumorigenic pathways (independent of
immune escape mechanism) can play crucial roles in the development of post-transplantation cancer. c-Met is
a receptor tyrosine kinase, which is significantly over-expressed in renal cancer. It can induce tumor growth by
modulating the redox pathway, angiogenesis and apoptotic events, through the regulation of cytoprotective
molecules Nrf2 and heme oxygenase-1 (HO-1). Nrf2/HO-1 has been shown to modulate the redox state of
cancer cells (by detoxification of reactive oxygen species, ROS), and to protect them from chemotherapeutic
drug-induced apoptosis. Interestingly, the c-Met-Nrf2-HO-1 pathway is also activated during the post-
transplantation period. The mTOR inhibitor RAPA is used in transplant patients to prevent organ rejection; and
interestingly, it also has anti-angiogenic potential, and is used for the treatment of renal cancer. However, the
RAPA responses are short lived, and most of the patients finally develop resistance. Prolonged RAPA
treatment cannot prevent post-transplantation cancer due to the activation of Akt by relieving the inhibitory
loop. Thus, new therapeutic approach needs to be developed for kidney cancer. Honokiol (C18H18O2), a novel
agent (isolated from Magnolia obovata), is being tested in pre-clinical models for its anti-tumorigenic potential.
In addition, Honokiol also has anti-inflammatory property, which can be utilized for the treatment of transplant
patients to sustain their immune suppression. In preliminary studies, we have observed that Honokiol treatment
can down-regulate c-Met-induced Ras activation (having cross-talk with Akt-mTOR) and inhibit Nrf2/HO-1 in
renal cancer cells. Together, Honokiol appears to be a promising therapeutic agent for c-Met-induced post-
transplantation renal cancer. We hypothesize that a combination therapy using Honokiol and the mTOR
inhibitor RAPA will not only prolong allograft survival, but also prevent c-Met-induced and Nrf2/HO-1-mediated
post-transplantation renal cancer. In the specific aims, we will: 1) study the mechanism(s) by which Honokiol
inhibits c-Met-induced tumorigenic signals in renal cancer cells through destabilization/inactivation of Nrf2/HO-
1 and regulation of the redox pathway (Aim-1), 2) examine how Honokiol treatment in the presence of mTOR
inhibitor RAPA can down-regulate c-Met-induced pathways for renal cancer growth and progression in vitro,
and in a tumor xenograft model (Aim-2), and 3) test the effect of Honokiol and RAPA combination therapy in
preventing early renal tumorigenesis and c-Met-induced post-transplantation renal cancer using novel murine
models (Aim-3). Our studies should lead to a paradigm shift to identify a novel combination therapy with
Honokiol to prolong allograft survival as well as to prevent c-Met-induced post-transplantation cancer.

Public health relevance
PROJECT NARRATIVE New therapeutic options need to be invented for kidney cancer, which is also a critical problem in transplant patients. A novel agent Honokiol (isolated from Magnolia Obovata) has both anti- inflammatory and anti-tumorigenic properties, which can be effectively utilized for the prevention/treatment of post-transplantation cancer. The proposed study will examine the effect of a combination therapy using Honokiol (in presence of the mTOR inhibitor rapamycin) on c-Met- induced renal cancer growth, with importance to post-transplantation cancer.